Proline metabolism in retinal health

PROJECT SUMMARY/ABSTRACT
Age-related macular degeneration (AMD) is the leading cause of blindness in the elderly. A common feature
in AMD is the early damage of retinal pigment epithelium (RPE), a monolayer of cells between photoreceptors
and choroid. RPE controls nutrient transport from choroid blood supply to the outer retina and multiple lines
of evidence show that the altered metabolism in RPE is the underlying mechanism for AMD. The long-term
goal of this project is to identify key metabolic features of RPE and the roles that they play in AMD.
We recently found that besides glucose, RPE preferentially uses proline, an amino acid, to fuel its metabolism.
Mutations of enzymes in proline metabolism in humans could cause chorioretinal atrophy or retinal
degeneration. The observation that a proline transporter is highly enriched in RPE but not in photoreceptors,
further supporting our finding. The proline transporter is a novel risk gene linked to AMD. In our preliminary
data, we show that knockout of the proline transporter blocks proine utilization and impairs visual function.
The objective of this proposal is to study proline metabolism in RPE and its role in retinal degeneration. We
plan to rigorously investigate the role of proline in healthy and diseased RPE using advanced tracer
methodology, mass spectrometry, in vivo infusion, live imaging, and proline transporter knockout mouse
models.
The outcome of this research will be to establish a conceptual framework for RPE metabolism that describes
how RPE uses nutrients to maintain metabolic homeostasis with the outer retina. This new knowledge will
provide the basis for understanding the mechanisms of AMD and lay the foundation for developing new
treatments.

Public health relevance
NARRATIVE Retinal pigment epithelial (RPE) cells have a unique metabolism that is altered in retinal degenerative diseases. Findings from our studies will provide fundamental knowledge for what RPE needs for its survival and function, and advance the understanding of the underlying causes of retinal diseases. 1